Outcomes Research in Rheumatic Diseases

Project Summary/Abstract
Outcomes research in rheumatic diseases
Dr. Dinesh Khanna is a professor of medicine at the University of Michigan (UM) and director of the UM
Scleroderma Program. He seeks the extension of the K24 Mid-Career Investigator Award in Patient-Oriented
Research (POR) to continue this successful research program while dedicating significant time for mentoring
the next generation of undergraduates, medical students, residents, clinical and post-doctoral fellows, and
junior faculty trainees. The goals of the K24 renewal application are to support the candidate's continued
impact as a mentor and assume leadership roles in collaborative POR programs, to continue the growth of a
research training program for POR at the UM, and to recruit new mentees who are interested in POR.
Since the successful funding of the initial K24 grant, the candidate has actively mentored trainees and junior
faculty on different POR projects who have published in peer-reviewed journals and received independent
funding. The candidate has launched successful collaborative links with other disciplines and institutions in the
pursuit of program excellence, and there is strong institutional support to create this program. The K24 grant
would preserve 30% of the candidate's effort and relieve future clinical and administrative responsibilities. A
diverse portfolio of currently funded research opportunities exists for future trainees in POR.
The research proposed includes four current projects and one new project addressing POR areas of patient
reported outcomes, outcome measures, and clinical trial design. The currently funded studies include: 1)
Taking charge of systemic sclerosis: Improving patient outcomes through self-management (funded by
PCORI); 2) Development of a systemic sclerosis-associated interstitial lung disease combined response index
(R01, funded by NIH/NIAMS); 3) An investigator-initiated, multicenter international phase II pilot study to
evaluate subcutaneous abatacept vs. placebo in diffuse cutaneous systemic sclerosis—a double-blind,
placebo-controlled, randomized controlled trial (funded by NIH/NIAID, University of Michigan Autoimmunity
Center of Excellence and Bristol Myers Squibb); and 4) A dose escalation safety study of brentuximab vedotin
in diffuse dutaneous Systemic Sclerosis (funded by NIH/NIAID/Immune Tolerance Network). The aim of the
new proposed study is to implementation the NIH Patient-Reported Outcomes Measurement Information
System (PROMIS®) in clinical practice using a pilot cluster randomized controlled trial.

Public health relevance
Project Narrative The goals of the K24 application are to support Dr. Khanna's continued development as a mentor and to sustain and expand a successful research training program for Patient-Oriented Research through an interdisciplinary program which focuses on expanding clinical research opportunities and mentoring in rheumatic diseases. The extension of the K24 Mid-Career Investigator Award would ensure that the candidate has significant time for mentoring current mentees. It would secure additional time to further recruit and train junior investigators, to secure ongoing research funds to support the proposed research and mentoring activities, and to continue to foster collaborative links with other disciplines and institutions in the pursuit of program excellence.